GERIATRIC LEADERSHIP ACADEMIC AWARD

This is an application for a Geriatrics Leadership Academic Award (K07). The candidate proposes to enhance aging research at the University of Texas Health Science Center at San Antonio by initiating the following activities: 1) elective course work in gerontology for professional students (medical students, dental students, nursing students, allied health sciences students) of the health science center; 2) course work in gerontology and gerontological research methodology as well as hands-on research experiences for the geriatric fellows of the clinical departments; 3) programs to broaden the scope of gerontological knowledge of graduate students and postdoctoral fellows of the basic science departments who are working intensively on indepth but necessarily narrow aspects of gerontological research; 4) programs which provide faculty of all five schools who have an emerging interest in gerontology with gerontological course work and hands-on experiences in gerontological research including the means to conduct pilot studies; 5) programs which catalyze the interactions between research groups of the health science center currently working in gerontological and related research; 6) a program which expands the breadth of the candidate in gerontology and geriatrics.